Testing a model of cortico-basal ganglia support for juvenile imitative learning in zebra finches

Project Summary/Abstract Juveniles acquire crucial skills by imitating skilled adults, as when infants imitate their parents' speech sounds. Evidence suggests that cortico-basal ganglia (CBG) circuitry critically supports this process both in general and specifically when juvenile zebra finches learn to imitate an adult tutor, an experimentally tractable phenomenon. A cortical pathway in juvenile zebra finches can generate stereotyped song that becomes more similar to tutor song over the course of learning. A song-dedicated CBG circuit influences activity in this pathway, acutely increasing the variability of song acoustics from rendition to rendition. My preliminary data suggest that the CBG circuit also acutely induces a directional shift in song acoustics, compared to song generated by the cortical pathway without CBG influence. The proposed experiments test the idea that the CBG drives rapid acoustic shifts, directed at the imitation target, that slowly consolidate in downstream motor cortical structures. To test this hypothesis, I have developed a (1) novel song analysis and (2) a novel longitudinal experimental design that uses (3) innovative optogentic techniques in this model system. These experiments have the potential to significantly advance our understanding of CBG support for zebra finch song learning, and to test CBG reinforcement learning models in a learning domain that does not require external reinforcement.

Public health relevance
Project Narrative Early in life, we must acquire crucial skills like speech by imitating adults, so neurological impairments of imitative learning can be debilitating. This proposal is relevant to human health because it will address how cortico-basal ganglia (CBG) circuitry supports juvenile imitative learning in a powerful laboratory model, song learning by zebra finches. Insight from the project's findings may improve our ability to relate CBG circuit biology to behavioral outcomes in normal and disordered juvenile imitative learning.